The Diabetic Wound Environment Shapes Group B Streptococcal Pathogenesis

PROJECT SUMMARY
Diabetic wound infections are a major public health burden, with approximately 25% of diabetic individuals
developing a wound in their lifetime, 25% of these wounds not healing and 28% requiring surgical amputation.
The diabetic wound environment is complex, with hyperglycemia driving immune dysfunction and bacterial
pathogenesis leading to poor infection outcomes. One of the most frequently isolated bacterial species from
diabetic wound infections is Group B Streptococcus (GBS). Interestingly, GBS is notoriously absent from non-
diabetic wounds, suggesting that components of the diabetic environment specifically influence GBS success in
this niche. Previously, I have developed two murine models of GBS diabetic wound infection and determined
that GBS promotes hyper-inflammation in vivo. Dual RNA-sequencing of the murine and GBS transcriptome has
identified multiple host and bacterial targets with altered transcription during diabetic infection that have informed
the hypothesis herein. This proposal therefore seeks to elucidate the environmental factors that promote GBS
infection of diabetic wounds. I hypothesize that multiple facets of the diabetic wound environment including
neutrophil function, hyperglycemia and polymicrobial interactions contribute to GBS success. This hypothesis
will be addressed via the following specific aims: Aim 1: Evaluate the consequences of altered neutrophil function
to GBS pathogenesis during diabetic wound infection. Aim 2: Determine how hyperglycemia contributes to GBS
pathogenesis in the diabetic wound. Aim 3: Examine the contribution of Staphylococcus aureus to GBS diabetic
wound persistence during polymicrobial infection. These studies will increase our understanding of how the
diabetic wound differs from the non-diabetic wound environment, and the consequences of that altered
environment on pathogen success.

Public health relevance
PROJECT NARRATIVE Diabetic wound infections are a major medical burden, as they are difficult to treat due to an improper immune response and the presence of dangerous bacterial pathogens. This proposal will investigate key aspects of the diabetic wound environment including the immune response, hyperglycemia, and polymicrobial interactions to provide insight into why many patients have poor healing outcomes. These studies seek to more fully understand the molecular mechanisms by which bacteria evade the diabetic immune system in this environment to inform more targeted therapeutic approaches.